Identifying the Role of Oral Health in Heart Disease through Integration of GWAS-by-Subtraction Genomic-Structural Equation Modeling with the Method of Instrument Variables

Project Summary
Our proposed project will build upon previous research which has shown an association between oral health
and systemic health, including the relationship between heart disease and periodontitis. We will benefit from
recent methodological advances in computational genomics and be the first study to provide causal evidence
about the postulated relationship between poor oral health and heart disease using nationally-representative,
longitudinal data. Specifically, we will construct polygenic scores using a GWAS-by-subtraction genomic
structural equation model that are suitable for use in instrumental variables estimation. To accomplish our
Aims, we will use longitudinal files containing 11 years of data (2006-2016) from the Health and Retirement
Study (HRS). This longitudinal database will provide over 22,000 older Americans producing a sufficiently large
sample size to overcome prior analytical obstacles.
Aim 1. Determine the strength of genetic risk factors for poor oral health. The working hypothesis is that
individual genetic composition is a strong predictor of poor oral health.
Aim 2. Determine the causal effect of poor oral health on the probability of heart disease (HD). The
working hypothesis is that variation in oral health due to individual genetic composition can be used to identify
the causal effect of poor oral health on HD.

Public health relevance
Narrative Our proposed project will build upon previous research which has shown an association between oral health and systemic health, including the relationship between heart disease and periodontitis. We will benefit from recent methodological advances in computational genomics and be the first study to provide causal evidence about the postulated relationship between poor oral health and heart disease using nationally-representative, longitudinal data. Specifically, we will construct polygenic scores using a GWAS-by-subtraction genomic structural equation model that are suitable for use in instrumental variables estimation. To accomplish our Aims, we will use longitudinal files containing 11 years of data (2006-2016) from the Health and Retirement Study (HRS). This longitudinal database will provide over 22,000 older Americans producing a sufficiently large sample size to overcome prior analytical obstacles.